Elucidating the Mechanisms that Underlie Tau Aggregation and Neurotoxicity

PROJECT SUMMARY/ABSTRACT
This proposal entails a five-year mentored career development plan that studies mechanisms of tau
aggregation in Alzheimer's disease and frontotemporal lobar degeneration. This proposal includes technical
training in iPSC-derived neuron cultures, CRISPR functional genomics and bioinformatics approaches, and in-
depth neuropathologic analysis. The training plan also incorporates skills required to maintain an independent
research group, including scientific communication, grant writing, mentorship skills, and lab management
strategies. To achieve these goals, the candidate, Dr. Sarah Kaufman, has assembled a multidisciplinary
mentorship team that includes Dr. Martin Kampmann (mentor), Dr. Bill Seeley (co-mentor), and advisory
members Dr. Bruce Miller and Dr. Jason Gestwicki. Together, this proposal will allow her to establish a
rigorous independent laboratory that combines her previous graduate training, clinical interest in Alzheimer's
disease and frontotemporal dementia, and scientific expertise in tauopathies to become a leader in
neurodegenerative disease research.
Tauopathies including Alzheimer's disease (AD) and frontotemporal lobar degeneration with tau inclusions
(FTLD-tau) are devastating neurodegenerative diseases that currently affect over 30 million people worldwide.
Tau aggregates in AD and FTLD-tau adopt unique, disease-specific conformations, or “strains,” that deposit in
selectively vulnerable neurons. Different tau strains are now believed to underlie the different disease
phenotypes and atrophy patterns observed across tauopathies. However, the mechanisms that give rise to
different tau strains and their link to selective vulnerability and neuronal loss are not known. Several human
induced pluripotent stem cell (iPSC) derived excitatory neuron (iNeuron) models have been developed to study
tauopathies. However, these models do not readily accumulate tau aggregates, which has hindered their use
when studying mechanisms of tau strains or selective vulnerability. This proposal describes the creation of a
novel iNeuron model that stably maintains full-length tau aggregates seeded from human tauopathies that are
associated with distinct tau strains. An initial large-scale CRISPRi screen identified several novel regulators of
tau aggregation in this iNeuron model, including the lesser-known ubiquitin-like UFMylation pathway that plays
an important role in protein homeostasis, and several RNA binding proteins known to directly interact with tau
protein. Aim 1 of this proposal will elucidate the role of RNA binding proteins in tau aggregation and selective
vulnerability across different tau strains, followed by analysis in human tauopathy subjects. Aim 2 will elucidate
the mechanisms by which UFMylation modulates tau aggregation in neurons. Together, the proposed research
will provide important insight into the mechanisms that underlie tau aggregation and the link between tau
strains and different patterns of selective vulnerability observed across tauopathies.

Public health relevance
Project Narrative Alzheimer’s disease and other tauopathies are characterized by the toxic misfolding and accumulation of tau protein aggregates in vulnerable neuron types. This project aims to identify the molecular pathways that lead to the misfolding and accumulation of aggregated tau across these different neurodegenerative diseases. This work will provide important insight into the underlying cause of these neurodegenerative disorders and may identify novel therapeutic targets to slow or prevent this process.